Enamelysin Processing Mechanisms in Amelogenesis

The goal of this application is to identify the key cellular and molecular steps for proper dentin–enamel
junction (DEJ) formation. Prior to mineral formation, ameloblasts and odontoblasts are separated by a base-
ment membrane. Cell signaling induces the ameloblasts to degrade the basement membrane, move into the
rough surface of the mineralizing dentin and secrete enamel matrix proteins that initiate enamel formation. As
ameloblasts and odontoblast cell bodies move away from each other when their respective tissues thicken, the
odontoblasts maintain functional cell processes within tubules that penetrate the entire width of the dentin. There-
fore, the odontoblastic processes are left near the basement membrane. Matrix metalloproteinase-20 (MMP20)
is expressed and secreted by both odontoblasts and ameloblasts. MMP20 has preferential (primary) and non-
preferential (secondary) enamel matrix cleavage sites and the cleavage site sequential order is essential for
proper enamel formation. MMP20 also cleaves cadherin ectodomains, which releases β-catenin from the inner
surface of the cell membrane. Strikingly, MMP20 ablation results in brittle enamel that falls away in sheets from
the underlying dentin. Conversely, over-expression of Mmp20 in mice results in significantly softer than normal
enamel that contains a cell infiltrate, which is attributed to increased β-catenin release and signaling. However,
the underlying mechanisms for how the DEJ normally develops into such a tough and resilient structure, and
how MMP20 regulates this process, remain unknown. This lack of knowledge presents a critical obstacle to our
understanding of tooth development. When we establish how MMP20 proteolytic processing supports DEJ for-
mation, it will lay the necessary foundation for future steps focused on designing highly effective biomimetic
adhesive materials. We will determine the mechanism by which Mmp20 ablation causes disruption of the DEJ
(Aim 1). We hypothesize that in normal development, MMP20 contributes to degradation of the basement mem-
brane and cleaves enamel matrix proteins, but in the absence of MMP20, this process is compromised so base-
ment membrane and matrix proteins remain intact and this may form a barrier that inhibits dentin–enamel ad-
herence. We will determine the impact of MMP20 over-expression on the DEJ (Aim 2). We hypothesize that
basement membrane hydrolysis and the cleavage order of enamel matrix proteins are required for proper DEJ
formation, and that MMP20 over-expression will cause the sites that are normally cleaved in series to be cleaved
all at once, resulting in a compromised DEJ, and that too much MMP20 also alters cell signaling. We will deter-
mine the extent to which the source of Mmp20 impacts formation of the DEJ (Aim 3). Although both ameloblasts
and odontoblasts secrete MMP20, we hypothesize that Mmp20 expression in odontoblasts, which have cell
processes near the DEJ, will rescue DEJ formation in KRT14-Cre-Mmp20fl/fl mice. The results are expected to
have an important positive impact because they fundamentally advance the field of dental research by defining
in molecular terms how enamel and dentin bind together with such strength.

Public health relevance
Project Narrative When the enamel gene MMP20 is mutated, the enamel becomes brittle and falls from the underlying dentin surface. Unfortunately, dental restorations, including adhesives binding to dentin, have a relatively high failure rate that can reach 17% after two years. We will determine how MMP20 functions to promote the normal, exceptionally strong bond between dentin and enamel so that this knowledge can eventually be used to engineer longer lasting dental restorations.